Computational Models of Mechanical Thrombectomy in Acute Ischemic Stroke Treatment

PROJECT SUMMARY
Stroke is the second leading cause of death worldwide, with acute ischemic strokes representing 87% of all
stroke cases. Given the number of individuals experiencing acute ischemic strokes, there is a pressing need to
improve therapies for this disease. A recent treatment for large vessel occlusion, which accounts for up to 46%
of all acute ischemic strokes and 98.8% of all poststroke mortality, is mechanical thrombectomy. The main forms
of thrombectomy include using a stent retriever to trap and extract the occlusive clot or an aspiration catheter to
remove the clot via suction. While this is an effective treatment for large vessel occlusion, studies show that only
50% of treated patients achieve good functional outcomes. Additionally, up to 40% of patients experience distal
embolization, where the clot breaks into fragments during removal; these fragments travel distally and cause
further damage to the cerebral vasculature. Individual studies have shown that adjusting treatment parameters
such as i) stent retriever length, size, and withdrawal speed, or ii) aspiration catheter size, distance from the clot,
and suction pressure improve patient outcomes. These studies are limited though, and no study has thoroughly
investigated the impact of all these treatment parameters on procedural outcomes such as i) degree of
recanalization, ii) number of passes needed to recanalize, and iii) occurrence of distal embolization for clots of
varied geometry, composition, and location. It has been noted that computational models could overcome this
gap; they can be used to systematically test all treatment parameters for clots of varied geometry, composition,
and location. The advantage of this approach is in the reduction of time and resources needed to study
thrombectomy treatments, as experiments can be difficult to perform, costly, and time-consuming. Despite this,
few computational models exist that capture the complex physics of thrombectomy, let alone investigate the
sensitivity of procedural outcomes to treatment parameters. To fill this gap, the proposed project aims to develop
and validate an open-source computational model of thrombectomy (Aim 1) and optimize thrombectomy for clots
of varied geometry, composition, and location using computational models (Aim 2). The aims will use state-of-
the-art techniques in experimental and computational biomechanics. Our current lack of knowledge is potentially
withholding better treatment strategies for large vessel occlusion in acute ischemic stroke. Thus, my ultimate
goal is to identify optimal thrombectomy treatment options and inspire the development of new thrombectomy
devices and strategies. Along with the research strategy, the fellowship training plan is organized to offer the
applicant professional development toward an independent research career in a top-tier institutional environment
at the University of Texas at Austin under the sponsorship of a leading expert in blood clot biomechanics. Upon
completion of the training program, the applicant will be ideally prepared for further postdoctoral training and
eventually a faculty position in cardiovascular disease research.

Public health relevance
PROJECT NARRATIVE Mechanical thrombectomy, while being effective in the treatment of large vessel occlusion in acute ischemic stroke, suffers drawbacks due to procedural complications that may occur during treatment, with up to 40% of treated patients experiencing distal embolization. Furthermore, optimizing mechanical thrombectomy procedures is limited by the little work done to investigate how procedural outcomes for blood clots of varied geometry, composition, and location are affected by treatment parameters such as i) stent retriever length, size, and speed of withdrawal, or ii) aspiration catheter geometry, distance from clot, and suction pressure. The proposed project develops a computational model of thrombectomy using experimental data from in vitro thrombectomy procedures to determine how the removal of clots of varied geometry, composition, and location is affected by the previously stated treatment parameters, which can inform further studies of mechanical thrombectomy to provide optimal treatments for large vessel occlusion in acute ischemic stroke.